Mechanisms of Microprocessor Function and Regulation

Project Summary/Abstract (30 lines)
MicroRNAs (miRNAs) constitute a large family of short, non-coding, regulatory RNAs that modulate protein
expression. Abnormal miRNA levels are associated with many diseases, including developmental defects and
various cancers. To generate functional miRNAs, primary transcripts (pri-miRNAs) generally need to be first
cleaved by an RNaseIII, Drosha. This critical step of miRNA biogenesis needs to be controlled, in both
accuracy and efficiency, to maintain proper gene regulation. The processing enzyme Drosha requires its
partner protein, DGCR8, for protein stability and substrate specificity. A Drosha molecule binds homo-dimeric
DGCR8 to carry out pri-miRNA processing, but higher-order complexes may also form because clustering of
pri-miRNAs in the genome enhances processing. Our recent groundbreaking cryo-electron microscopy (cryo-
EM) structures provide atomic models of the Microprocessor-pri-miRNA complex in action. Elucidating how the
proteins are organized around the RNA stem-loop also revealed how each distal end (basal or apical) is
independently recognized but also linked to each other via a molecular ruler connecting the detection modules.
The proposed research builds on our previous successes, as the structural framework will enable us to gain
novel fundamental insights into how the macromolecular recognition is accomplished. Our overall goal is to
understand the recognition of pri-miRNAs by Microprocessor at the molecular level. We hypothesize that RNA
structural features and context-dependent sequence preferences dictate the processing fate of each individual
pri-miRNA. We will dissect how the recognition is accomplished at each of the basal and apical junctions of pri-
miRNAs. We will also investigate how diverse RNA sequences and structures from different pri-miRNAs affect
proper recognition at each junction, to reveal the plasticity of the multipart machinery. Our previous work has
also left us poised to address urgent questions on how clustering of pri-miRNAs enhances processing by
Microprocessor, which is crucial for our overall understanding of miRNA biogenesis and has profound
implications for the interpretation of previous and future results in a wide variety of fields obtained by
manipulation of miRNA genes. A better grasp of the core recognition mechanisms will help us explain unique
targets such as clustered pri-miRNAs. Together, the proposed studies will provide a comprehensive
understanding of processing and regulation of miRNAs, important regulators of gene expression. Our work on
deciphering how structure affects RNA recognition is a fundamentally important question and likely be
insightful for many processes involving structured RNAs beyond miRNAs.

Public health relevance
Project Narrative (2-3 sentences) As a class of endogenous regulatory molecules, microRNAs play a key role in proper gene expression and are necessary for stem cells maintenance, cellular and organ development, response to cellular signaling or stress, and proliferation. Almost all microRNAs undergo mandatory maturation steps to become functional and understanding the molecular mechanism of microRNA biogenesis and its regulation will be fundamentally important for a wide range of diseases including cancer, developmental diseases, diabetes, and metabolic syndromes.